Immunological changes associated with antibiotic use in oropharyngeal cancer

Project summary/Abstract 30 lines
Antibiotics are widely used to prevent infections, however, their use has been associated with reduced
overall survival of oropharyngeal cancer patients. The underlying mechanisms by which this occurs is in
part because of the effect antibiotics have on the gut microbiota which shape immune responses against
tumors. Although most research has focused on the effect of antibiotics on the gut microbiota, limited
studies have identified the impact of antibiotics on the oral microbiota and immune responses during
oropharyngeal cancer development. We hypothesize that antibiotic use leads to a decrease in microbial
diversity which impairs anti-tumor immune responses and therefore promotes oropharyngeal cancer
development. For this, we will utilize preclinical models to compare the effect of oral and topical
tetracycline application (common antibiotic used as preoperative prophylaxis in oropharyngeal cancer
patients) on cancer treatment responses (Aim 1) and intratumoral microbial and immune changes (Aim
2). Since high-risk human papillomavirus cause oropharyngeal cancer, we will also recruit women
infected with HPV to collect saliva for immune cell phenotyping and cytokine and microbiota profiling (Aim
3). We will compare immune and microbial profiles between patients who were taking or not antibiotics.
Banked saliva samples will also be used. Results from this study could potentially change clinical
practices by providing evidence of the impact antibiotics have on immune responses in the oral cavity
which may impair oral health, cancer risk, and prognosis of oropharyngeal cancer patients. We will also
be able to identify bacteria eliminated by antibiotics to develop therapeutics to recover the loss of
beneficial bacteria in Hispanic women.

Public health relevance
Project narrative This project aims to determine the effect of antibiotic use on the microbiota, immune responses and cancer treatment responses in oropharyngeal cancer preclinical models. We will also analyze the saliva of patients with high risk of developing cancer to identify changes in the microbiota, immune cells, and cytokines associated with antibiotic use. We could identify bacteria eliminated by antibiotics to develop novel therapeutics, as well as impact clinical practice related to the use of antibiotics.